Career Enhancement Program

Project Summary/Abstract – Career Enhancement Program
The development of talented junior faculty into future leaders in their respective fields is a key goal of all successful research organizations. The Fred Hutch Lung SPORE Career Enhancement Program (CEP) identifies and nurtures the careers of promising junior investigators and senior faculty interested in re-focusing their programs on lung cancer translational research. This has been accomplished through a calculated solicitation process to identify all talented junior investigators at the post-doctoral fellow level (must be in last year of training) and junior faculty level. Going forward, we will also solicit applications from senior investigators who wish to re-focus their research programs on translational lung cancer research. A thorough review process will be performed by a highly accomplished panel of senior leaders at our Center who comprise the CEP Committee. In conjunction with the Executive Committee (EC), final award decisions will be made. The CEP Committee closely monitors the progress of CEP Awardees throughout the duration of the award. The EC and CEP Committee will ensure that the awardees become immersed within the Lung SPORE and benefit from the research expertise and available core resources. Self-assessments have been made by the Committee such that the effectiveness of the program is carefully monitored and so that necessary adjustments can be made.